Bionic Self-Charged Bone Composite Scaffold

Abstract
Reconstruction of large and major bone defects remains a significant challenge in modern medicine. The golden
treatment so far has been to use replacement auto or allo-grafts which however struggle with problems of
immune rejection, infection, donor-site morbidity and especially, limited tissue supplies. Tissue regenerative
engineering approach relying on biomaterials to construct artificial “engineering” bone grafts has therefore
become an important field. While many biomaterials are safe, they often require an addition of potentially-toxic
growth factors, stem cells, biologics or drugs to promote healing and tissue regeneration. In fact, there has not
been any clinical success to heal critical-sized (large) bone defects by using only a safe biomaterial scaffold that
is free of seeded stem-cells, exogenous growth-factors, biologics or drugs. Electrical stimulation (ES) has been
shown to effectively promote bone healing and could offer a safe natural stimulation as bioelectrical signals are
ubiquitous inside the body. Several electrical stimulators are available in the market and used clinically for bone
healing. Yet, while external stimulators are not very effective, implanted devices rely on toxic batteries. Several
researchers have attempted to pre-induce electrical signal (i.e. surface charge) on the surface of biomaterial
scaffolds to promote bone healing and avoid the use of battery-based ES. This method however only creates
transient charge that quickly gets neutralized when the scaffold is implanted or directly interfaced with living cells.
In this regard, piezoelectric materials, which can always produce surface charge when subjected to external
force or vibration, appear to be an excellent choice to create a battery-free and remotely controlled electrical
stimulator. Unfortunately, common piezoelectric materials are also non-degradable and/or even toxic, which
renders them not favorable for serving as implanted tissue scaffolds. Here, we propose a novel bionic bone
composite scaffold (BBCS) which is completely biodegradable and can be remotely activated by ultrasound (US)
to electrically stimulate bone regeneration via the combination of piezoelectric self-charging effect and osteo-
inductive ions released from the degradation of beta-Tricalcium Phosphate (β-TCP). This will be the first pure
biomaterial scaffold without using any exogenous stem cells, growth factors, drugs or any biologics to heal a
large bone defect. We design the project with three specific aims; Aim 1 is to assess piezoelectric charge,
mechanical/degradation properties and osteogenesis of the piezoelectric BBCS with US activation in vitro. Aim
2 is to assess healing of critical-sized long-bone defects, using the BBCS and US activation in vivo. And Aim 3
is to study the molecular mechanism to understand the engineering rules on how the BBCS can induce and
enhance osteogenesis of stem cells.

Public health relevance
Narrative Reconstruction of large and major bone defects remains a significant challenge in orthopedic surgery. Yet, the golden treatments so far, using replacement auto or allo-grafts, struggle with many problems of immune rejection, infection, donor-site morbidity and especially, limited tissue supplies. Here, we propose a new approach to combine special biodegradable piezoelectric Poly-l-Lactide (PLLA) nanofibers with Tricalcium Phosphate (β-TCP) to create a bionic bone composite scaffold which can be activated by ultrasound (US) to electrically stimulate a complete healing of critical-sized bone defects in vivo.